Metabolic/gas exchange system

PROJECT SUMMARY
This application requests funding to purchase a Metabolic/Gas Exchange system. The state-of-
the-art Metabolic Gas Exchange system is the only system with accessories made compatible with
magnetic resonance imaging (MRI) to acquire a wide range of breath-by-breath gas exchange and
pulmonary function parameters. In addition, a set of comprehensive vital monitoring tools will be
equipped to ensure the safety of the research subjects and the needs of physiological recordings in
different clinical and hardware/software development research at the Martinos Center, across different
departments at MGH, as well as different institutions in the Boston area.
The proposed Metabolic/Gas Exchange system is especially important to ensure the continuity of
the existing funded projects and the synergistic research in the future. The system not only serves as
a replacement of the existing equipment constructed with separate pieces of outdated devices that
are nearly worn out but also provides a wider opportunity for synergizing research in the study of brain
activity in association with pulmonary function and gas exchange. For example, one major area in
the near future is mechanistic and clinical research for the potential upcoming rehabilitation pandemic
of long COVID, which involves studying the interaction between the brain, pulmonary system, and
cardiovascular system.
The proposed Metabolic/Gas Exchange system will be located within the Athinoula A. Martinos
Center for Biomedical Imaging, MGH. The Martinos Center has a renowned biomedical imaging
program, consistently producing successes with imaging modalities such as MRI,
magnetoencephalography (MEG), positron emission tomography (PET), and optical imaging. The
proposed system will be fully utilized in the existing and future imaging research on this successful
imaging platform for the users at Martinos Center and the other institutions in Boston.

Public health relevance
PROJECT NARRATIVE The proposed Metabolic/Gas Exchange system is a state-of-the-art system capable of measuring a wide range of breath-by-breath gas exchange and pulmonary function parameters. It will be made compatible with different imaging modalities, including MRI. The system will provide a shared resource for researchers in the institution and the research communities in the Boston area performing imaging research in conjunction with measuring gas exchange and pulmonary function.